Systematic Identification and Mechanistic Characterization of Novel Oxidative Protective Genes to Prevent RPE Degeneration

Project Summary / Abstract
Age-related macular degeneration (AMD) affects approximately 196 million people globally and
is primarily caused by oxidative stress in the retinal pigment epithelium (RPE) cells. These
crucial cells lie between the oxygen-rich choroid and the photo-oxidatively stressed retina,
making them highly susceptible to damage from reactive oxygen species (ROS). Given the
prevalence of AMD and the lack of highly effective treatments, there is a pressing need for novel
interventions that enhance the oxidative defense mechanisms of RPE cells. In this project, I
have initiated, to my knowledge, the first-ever genome-wide overexpression screen
specifically in RPE cells, identifying ten novel gene candidates that enhance cell
survival against oxidative stress, particularly NaIO3 which is known to cause mitochondrial
dysfunction. Among these, the cardiac-specific transcription factor NKX2-5 emerged as a
standout due to its potential to confer heart-like antioxidative properties to RPE cells.
Preliminary data suggest that NKX2-5 can significantly ameliorate oxidative stress in these
cells, thereby potentially mitigating AMD progression. The project is structured into three
primary aims: Aim 1 focuses on elucidating the mechanistic pathways through which
NKX2-5 confers oxidative protection, including direct ROS reduction, enhancement of
mitochondrial biogenesis, and activation of anti-apoptotic pathways. This will be assessed using
iPSC-derived RPE cells expressing NKX2-5, where cellular ROS levels, mitochondrial
metrics, and genomic changes will be evaluated. Aim 2 tests the hypothesis that NKX2-5 can
improve both the morphology and function of RPE cells in vivo. This will involve developing a
new adeno-associated virus (AAV) construct for inducible NKX2-5 expression specifically in
RPE cells, which will then be administered in both an acute model of RPE degeneration
and in aged mice to assess improvements in RPE health and visual function. Aim 3 expands the
investigation to include all identified genes from the screen, assessing their ability to protect
against various oxidative stressors relevant to AMD, such as oxidized-LDL and cigarette smoke
extract. The ultimate goal is to identify gene combinations that provide the broadest
oxidative protection. These combinations will be tested in a comprehensive mouse model of AMD
that incorporates genetic risk factors, a high-fat diet, and aging influences. Throughout this project,
I aim to gain a deep understanding of cellular defense mechanisms against ROS, paving the way
for novel gene therapy approaches to treat AMD and potentially other ocular diseases influenced
by oxidative stress.

Public health relevance
Project Narrative Increased oxidative stress in aging retinal pigment epithelium (RPE) cells is a major trigger for the development of age-related macular degeneration (AMD), suggesting that interventions making RPE cells resistant to oxidative stress may slow or reverse the disease progression. I applied, for the first time, a genome-wide overexpression screen to identify ten gene candidates that significantly enhance RPE survival against oxidative agents. My research will study these top gene candidates and identify their protective mechanisms in RPE cells, in vitro and in vivo, and eventually testing synergistic gene combinations that provide a broad spectrum of protection to a variety of oxidative agents in vitro and effective protection in a comprehensive AMD mouse model in vivo.